2023 Biomaterials and Tissue Engineering

Summary
The Biomaterials and Tissue Engineering Gordon Research Conference and Seminar is a highly successful
venue for bringing together ~200 world-class biomaterial scientist, clinicians, and basic scientist to discuss
materials-related strategies to treat disease ranging from cancer to tissue repair. This proposal seeks support
for the Gordon Research Conference and Seminar on Biomaterials and Tissue Engineering to be held July 16-
21, 2023 (delayed from 2021 due to the COVID-19 pandemic). Requested funds will be used to support the
registration for faculty, researchers, postdoctoral fellows, and graduate students who attend the conference, with
priority going to support the participation of members of underrepresented groups, i.e. women, minorities and
persons with disabilities. The 2023 meeting will focus on the design, function, and translation of bio-instructive
materials, with a particular emphasis on material modulation of biological activity. This conference proposal is
divided into three aims. Aim 1 is to provide a cutting-edge scientific program. Aim 2 is to facilitate the exchange
of ideas, collaborations, and relationship building between diverse attendees. Am 3 is to setup next generation
researchers for success. Scientifically, this GRC will highlight cutting-edge advances to understand how material
properties and material-biomolecule conjugation strategies affect biological activities and have thereby enabled
the application of instructive biomaterials in fields including tissue engineering, regenerative medicine, immune
engineering, and diagnostics. This GRC will also explore the multifaceted challenges associated with the clinical
translation and commercialization of biomaterials. Aside from a strong scientific component that is the backbone
of the conference, the 2023 program also adheres strongly to the GRC directive of holding vigorous formal and
informal discussions among prominent investigators in biomaterials and tissue engineering, junior attendees of
the conference, and researchers from underrepresented groups. All meals and breaks will encourage interaction
between junior and senior and diverse groups. Further, conference organized activities are free of charge to
allow everyone to be included and benefit from networking and mentoring. Last, this conference will feature a
Gordon Research Seminar (GRS) that will directly precede the Conference. Organized by two post-doctoral
fellows with experience in the fields of Biomaterials and Tissue Engineering, the Seminar will be oriented to
senior doctoral students and post-doctoral researchers.

Public health relevance
Narrative Biomaterials and tissue engineering are central disciplines required for the successful development of existing and future biomedical devices. This conference provides a forum for the discussion of cutting edge, integrative research that focuses on the path from basic science and engineering to commercial translation to the clinic and training the next generation workforce. The conference theme, “Design, Function and Application of Instructive Materials” will focus on multidisciplinary efforts integrating stem cell biology, materials science, immunology, and biochemistry seeking to solve clinically relevant biomedical problems.